HOE 901 INSULIN W/ NPH INSULIN IN TYPE II DM PTS

The purpose of this study is to see whether HOE 901 is safe, lowers glycated hemoglobin, and controls blood glucose levels in subjects with non-insulin dependent diabetes.